G-Quadruplex-Based Supramolecular Assemblies as Activatable Contrast Agents for In Vitro and In Vivo Fluorescence Imaging of Estrogen Receptor

PROJECT SUMMARY/ABSTRACT
One in four women undergoing lumpectomy require a repeat surgery because of positive margins. One of the
underlying challenges in breast tumor margin assessment is a lack of fast, sensitive and reliable intraoperative
tools. Fluorescence-guided surgery (FGS) using activatable contrast agents (ACAs) is emerging as an
intraoperative tool for margin assessment during lumpectomy. Current design approaches to ACAs used in the
clinic have been limited to targeting extracellular or cell surface proteins and they rely on covalently attaching a
fluorophore and a quencher to a peptide substrate. Protease cleavage of this substrate separates the fluorophore
quencher pair thereby resulting in activation of fluorescence. A major disadvantage of this approach is that
cleavage of the peptide substrate occurs indiscriminately in both normal and malignant tissues giving rise to false
positive signals. Studies have shown higher false positive rates with protease-targeting ACAs than with standard-
of-care pathology. One could potentially circumvent this disadvantage by targeting alternative breast cancer-
specific proteins. However, in the absence of a suitable design approach for non-protease ACA targets, it is not
currently feasible to target non-enzymatic molecules. Here, we propose a new design paradigm that could be
applied to detect any intracellular ligand-binding protein. We demonstrate our new approach with the estrogen
receptor (ER) – a nuclear hormone receptor – which is upregulated in >70% of invasive breast cancer cases and
is expressed at 8-10 times higher levels in tumor cells compared to normal cells. In our approach to developing
ER-targeting ACAs, we propose to use supramolecular assemblies constructed from G-quadruplexes as hosts
and bifunctional estrogens as the fluorescently activated moiety. The latter consist of a G-Quadruplex-binding
fluorophore linked to an ER-targeting ligand. When bound to the G-quadruplex, emission of the fluorophore is
quenched by guanines. In the presence of ER, binding of the ligand moiety displaces the fluorophore from the
G-quadruplex supramolecular assembly thereby turning the emission “on”. In aim 1, we propose to optimize and
characterize a panel of G-quadruplex supramolecular assemblies targeting the ER. In aim 2, we propose to
validate the efficacy of the G-quadruplex assemblies compared to free probes for the specific detection of ER in
vitro and in vivo. Our new design approach has broad applicability to any cancer-specific protein regardless of
cellular location.
With successful completion of aims 1 and 2 we will achieve our overall objective of using G-quadruplex
assemblies as fluorescent ACAs to detect ER+ breast tumors. The establishment of a new design paradigm in
general and the availability of ER-targeting ACAs will diversify the pool of targeted biomarkers for FGS to
enhance the sensitivity and specificity of intraoperative margin assessment and ultimately improve patient
outcomes.

Public health relevance
PROJECT NARRATIVE A quarter of women who undergo lumpectomy are subject to repeat surgeries because of residual cancer tissue that is detected after the patient is discharged. We propose to address this problem by developing new fluorescent molecules that make breast tumors light up in real time during surgery so that the tumor mass can be removed in its entirety. The new fluorescent molecules specifically light up in the presence of estrogen receptor which is found in most breast tumors.